Targeting MBD2 for medulloblastoma therapy

PROJECT SUMMARY
The present proposal aims to develop novel small molecules for epigenetic therapy of medulloblastoma
(MB) with the goal of translating them to the clinic. MB is the most common and aggressive malignant brain
tumor in children. Current nonspecific cytotoxic therapies cure only a fraction of patients, and cause life-long
neurological, intellectual, and physical disabilities, highlighting the urgent need for novel therapeutic
approaches. ADGRB1 (BAI1) is an adhesion G protein-coupled receptor (GPCR) specifically expressed in the
brain, where it functions as a tumor suppressor. We have recently shown that ADGRB1 expression is
significantly reduced in patients with MBs across all 4 main molecular groups because the ADGRB1 gene
promoter is epigenetically silenced through CpG island methylation. We showed the involvement of methyl
CpG binding protein 2 (MBD2) in the switch to a silent chromatin conformation and demonstrated that we could
reactivate the gene through a novel small molecule inhibitor of MBD2 (KCC07). This lead compound
significantly extended the survival of mice carrying human MB xenografts in the cerebellum and sensitized
them to radiotherapy, providing proof-of-principle for the further development of this chemotype as a new drug
for patient treatment. Importantly, KCC07 had excellent brain distribution, was very well tolerated by the mice
and no overt toxicity was observed. We propose to perform medicinal chemistry to further optimize this
promising chemical scaffold and conduct further IND-directed preclinical studies towards identifying a
candidate compound to be evaluated in clinical trials. The proposed study has the potential to generate a new
epigenetic therapeutic for children suffering from this disease and improve their survival with reduced side
effects.

Public health relevance
PROJECT NARRATIVE Medulloblastoma is a deadly brain tumor that affects infants, children, adolescents and young adults. New therapeutic options have to be developed to reduce the mortality, side-effects of current therapies and improve the quality of life of these patients. The present project aims to develop and test novel small molecules for epigenetic targeting of medulloblastoma, with the ultimate goal of identifying a new drug candidate that can be translated to the clinic.